Integrating cancer datasets for predictive model development and training

Our proposal for a Sage CCSB,

Public health relevance
The massive generation of molecular information in oncology will not in itself change cancer death rates. This highlights the need to transition from archiving and binning facts to building predictive models of disease that help patients. Probabilistic causal models with curated data will allow early detection markers and directed therapies as well as predicting outcomes. The Sage CCSB will enable this distributed model building, while training scientists, building interface tools, and linking models between sites.